Tufts Clinical and Translational Science Institute

TUFTS CTSI OVERALL PROJECT SUMMARY
Over its 14 years, Tufts Clinical and Translational Science Institute (CTSI) has brought together partners
and collaborators and has grown programs and activities to catalyze clinical and translational research (CTR)
and to advance innovation in clinical and translational science (CTS). We focus on what we are best suited to
do, based on our skills, resources, partners, and opportunities. Thereby, we provide outstanding services,
resources, education, and mentorship, and conduct innovative research contributing to the field of CTS, locally
and nationally. With this application, retaining our important structural features of integration across all of Tufts
University, of having purposefully-selected partners, and adhering to our foundational principles, we are
pleased to further grow our offerings and ambitions leveraging our long-standing partners’ contributions and
assets and by adding the special assets of new partners.
With growth, our foundational principles have not changed. We actively support the full spectrum of
translational research, we practice “broadly-engaged team science,” and we are active collaborators,
embracing our role as “the extrovert CTSA.” We believe that only by having systems and processes to
continually assess and improve methods and operational principles will we achieve CTR/CTS excellence. We
practice inclusive communications and work to advance health equity. And we insist that wherever work is on
the T.5-T4 continuum, CTR must have a clear line of sight to potential ultimate impact on health. In addition to
these foundational principles, in all we do, we reflexively look for opportunities to contribute novel research
methods. Development, demonstration, and dissemination of new methods and approaches are hallmarks of
our work, regardless of domain. Also, we manifest our belief that rigorous role-specific inclusive education and
training are fundamental to excellence and advancing CTR/CTS.
In service of these principles, our aims are: Overall AIM 1: Harness the collective impact of Tufts CTSI to
advance CTS and improve public health through responsive Hub leadership, an inclusive and collaborative
culture, and continuous improvement of programs and research. Overall AIM 2: Provide outstanding
education, training, and mentoring, tailored to different roles and disciplines, to develop an expert and diverse
CTS workforce, and share these resources nationally. Overall AIM 3: Cultivate broadly-engaged team
science, with active inclusion of all stakeholders, to promote relevant and impactful translation for diverse
populations and to promote health equity. Overall AIM 4: Create the environment, resources, and services to
stimulate and support the full spectrum of CTS by leveraging the diverse expertise and assets of Tufts CTSI
partners. Overall AIM 5: Foster translation by developing, demonstrating, and disseminating innovations that
address significant translational roadblocks and provide generalizable translational insights and solutions.

Public health relevance
PROJECT NARRATIVE Through research resources and services, education, and clinical and translational science research, Tufts Clinical and Translational Science Institute supports the entire spectrum of translation to help meet the promise and the public’s needs of biomedical science. This includes the translation of preclinical investigation (“T.5”), into bench research into bedside care (“T1”), into effective clinical practice (“T2”), into wide care delivery and public health (“T3”), and into health policy (“T4”). By doing this, we support clinical and translational science and research that will have impact on health and health equity.